TREAT AD Admin

PROJECT SUMMARY ADMINISTRATIVE AND DATA CORE
The Emory-Sage-SGC-Jax TREAT-AD Center Administrative and Data Management Core (Admin Core)
serves four functions: serves four primary functions: (1) to provide overall administrative organization, oversight
and management for all work performed within the Center, (2) oversight of target portfolio, (3) to support the
open distribution of all TREAT-AD generated reagents, tools, probes, data, and knowledge, and (4) to inform
and engage the broader research community in the use of Center outputs. The Admin Core is led by MPIs
Levey (Emory), Greenwood (Sage), Edwards (SGC), and Carter (Jax), who together will establish and
implement administrative and management structures to ensure that the Center is appropriately meeting
milestones and deliverables, is openly sharing assets across the community, and is working across Cores for
effective evaluation and management of target programs as they move through the Center pipeline. In addition,
the Admin Core will manage interactions with the external research community to evaluate a set of targets
across a diverse portfolio of therapeutic hypotheses, to identify domain experts that can serve as partners to
guide decisions around each therapeutic hypothesis that is selected, and to identify researchers that will use
the assets developed by the Center to test these (and other) therapeutic hypotheses.
The specific aims of the Admin Core are:
1. Provide strategic oversight and administrative support across the Center.
2. Openly distribute all data, methods, reagents, tools, and resources from TREAT-AD.
3. Maximize the impact of TREAT-AD resources through outreach and engagement with the broader
research community.

Public health relevance
The narrative is attached in the Overall section.